Training Researchers in Clinical Integrative Medicine (TRIM) - NOSI supplement

PROJECT SUMMARY/ABSTRACT
Integrative medicine, including meditation, yoga, tai chi, massage, and other modalities are widely used by
Americans in the hope of obtaining health benefits. Evidence for the health effects of these practices, however,
has important limitations. The goal of the “Training for Research in Integrative Medicine” (TRIM) fellowship is to
train outstanding pre- and postdoctoral behavioral and social scientists, physicians, and other qualified health
professionals to design and conduct rigorous clinical and translational research in preparation for research
careers in integrative medicine. The program has four postdoctoral positions and two predoctoral positions.
The UCSF Osher Center for Integrative Medicine provides an exceptional context in which to offer the
program, and TRIM is designed to leverage the extensive training opportunities available as a result of being
embedded in the rich UCSF research environment. The current supplement is aimed at further advancing the
goals of the TRIM program by adding an integrative health practitioner, Leena Padya, ND, who has
outstanding potential to gain advanced research skills in the TRIM program and thereby impact the field of
integrative health research. We have developed a research and training plan for Dr. Padya that includes
getting a Master’s degree in advanced clinical research, and working closely TRIM faculty on an NCCIH
funded R34 study of whole body hyperthermia for depression. Since its inception 14 years ago, TRIM has
maintained a record of attracting extremely well qualified candidates who collectively have had a substantial
impact on the field of integrative medicine research. Ten of 22 post-doctoral fellows who have completed
training have gone on to receive K career development awards. The TRIM program provides an
interdisciplinary clinical and research environment; strong mentoring by an experienced research faculty;
advanced training in clinical, biological, and psychological research methodologies; special attention to
research methodology issues that are particularly relevant to integrative medicine research; extensive training
in methods to enhance reproducibility in research; opportunities to conduct original research; training in
research ethics; and exposure to diverse integrative approaches to patient care involving all age groups from
early childhood through old age. The interprofessional TRIM faculty is strongly committed to mentoring and has
11 core and 10 affiliated members representing internal medicine, family medicine, psychology, neuroscience,
molecular biology, anthropology, biostatistics, psychoneuroendocrinology, women’s health, pediatrics, health
services research, medical ethics, and psychiatry. TRIM faculty provide expert and comprehensive mentoring,
as well as required and optional academic activities that are tailored to each trainee’s individual learning
objectives. The program is strongly committed to addressing issues of health equity and diversity, equity, and
inclusion among its faculty and trainees; as one metric, 43% of pre-doctoral fellows in the last four years are
underrepresented minorities in medicine.

Public health relevance
PROJECT NARRATIVE Integrative Medicine modalities that may improve health, including meditation, yoga, tai chi, acupuncture, and massage, are widely used by Americans. Evidence for the health effects of these practices, however, has important limitations. This T32 grant will train outstanding pre- and postdoctoral scientists to perform well- designed research on integrative medicine approaches, and the training program will prepare a new generation of researchers to expand our understanding of whether and how integrative medicine approaches work for specific health conditions.